Exploring new approaches for enhanced human gene annotation

Project Summary
This project will support our work on computational methods for gene finding with the specific goal of
improving human gene annotation. The human gene catalog has a tremendous impact on biomedical research,
and a huge and ever-growing number of genetic studies depend on this list. Until we have a complete and
accurate catalog of all human genes and transcripts, including variants that appear in abnormal tissues and
tissue states, we will be unable to discover all the genetic causes of disease. Over the years we have developed
many innovative and efficient systems to identify genes, and during the last decade our focus has shifted
towards using the data produced by the RNA sequencing (RNA-seq) technology, which has revolutionized the
methodology of gene discovery. The most widely-used of our systems is StringTie, a genome-guided
transcriptome assembler that produces significant improvements over competing methods, both in terms of
accuracy as well as efficiency. During the last few years, we adapted StringTie in response to new technology,
and released several major new updates to StringTie, including a version that is capable of handling mixed
transcriptomic data and achieves assembly and quantification results that are better than long-read, short-
read, or corrected long-read assemblies alone. StringTie has an enormous user community, with more than
75,000 new users and software downloads over the past three years. The StringTie papers, combined, have
accumulated more than 13,100 citations, and this number continues to grow. Due to the high efficiency of
StringTie, we were able to use a massive RNA-seq database to build CHESS, a new human gene catalog that
represents a comprehensive, reproducible, and open method for annotating the human genome. Our work on
CHESS has highlighted the presence of a vast amount of transcriptional noise which leads to systematic errors
in the ability of leading computational methods to assemble and quantify the genes and transcripts in RNA-
sequencing experiments, which in turn impacts downstream assessments of variant impact. During our future
work, we will be addressing today's exponential growth of RNA-seq data, and we plan to develop efficient
algorithms that are able to process and summarize enormous data sets in order to make large-scale
transcriptome analyses faster and much more accurate. Our efforts will focus on improving gene annotation by
developing methods to aggregate transcriptomic evidence across thousands of RNA-seq data sets, with goals
that include identifying transcript features that are conserved across samples, and creating maps of functional
transcriptional activities that are characteristic of different cell and tissue types, developmental stages, and
disease types. As a result, we envision creating a database of clinically relevant transcription profiles, for which
we will then build new and robust methods to identify differential expression signals across all the conditions
in our database. As has always been the case in the past, we will also continue to adapt our methods as well as
create new systems in response to new technology.

Public health relevance
Project Narrative Identifying the genes that are active in a cell is a critical step in studying cell development, genetic diseases, responses to infection, the effects of mutations, and much more. During the last decade, high-throughput RNA-sequencing data have proven essential to characterizing the genes expressed in different cell types and conditions, which in turn has driven a strong demand for highly efficient, scalable, and accurate computational methods to process these data. This project will design and implement new algorithms to process the ever-growing and diverse types of RNA-sequencing experiments in order to produce more accurate human gene and transcript annotation.